Realizing the radiobiological impact of protons and high-LET particles in head and neck cancer and glioblastoma models

Project Summary
Radiotherapy is still one of the most effective cancer treatments used to treatment ~50 % of all human
cancers, and particularly solid tumours of the head and neck and brain. However, acute and long term
adverse side effects of radiotherapy are still common, and some tumours are also resistant to the
therapeutic effects of the radiation. The increased use of precision particle radiotherapy, particularly proton
beam therapy, enables the radiation dose to be delivered precisely to the tumour, which spares the
surrounding normal tissues of any unwanted radiation dose and is therefore able to limit some of the
adverse side effects. Furthermore, the ability to deliver radiation that causes extensive damage to the
tumour tissues (so called “high-LET”) is also a significant advantage in effective radiotherapy. However
despite this, there is still uncertainty regarding the biological effects of protons and high-LET radiation on
both normal and tumour cells and tissues, and how the radiotherapy can be optimised for patient benefit.
This proposal brings together world leading experts in radiation physics, biology and clinical oncology to
reveal new knowledge of the biological impact of protons and high-LET radiation versus conventional (x-
ray) radiotherapy, on cell models of head and neck and brain tumours. This will be performed on both 2-
dimensional, but also 3-dimensional cell models of the tumours which are more similar to those observed
in patients. We will thoroughly analyse the precise effect of protons and high-LET radiation at the molecular
(DNA) level, and how this correlates with the impact on overall survival of the cells. We will also investigate
the role of important factors such as low oxygen levels (hypoxia) which is important in driving resistance of
solid tumours of the head and neck and brain to radiotherapy, but also the rate at which the radiotherapy is
delivered (particularly high dose rates, so called “FLASH”), on the biology and survival of the tumour versus
the normal cells. Additionally, we will identify the combination of specific drugs and inhibitors under the
various conditions that are more effective in combination with protons and high-LET radiation in optimising
tumour cell killing, whilst sparing the associated normal cells.
In the long term, our research will contribute to the identification and development of more effective
strategies using radiotherapy, including proton beam therapy, for tumours of the head and neck and brain
that are particularly resistant to the radiation treatment. This will lead to an improvement in the patient
response but also in overall survival following precision particle radiotherapy.
1

Public health relevance
Project Narrative This project will enhance our basic understanding of the biological effects of precision particle radiotherapy, particularly proton beam therapy, on normal and tumour cells, with a focus on cells derived from solid tumours of the head and neck and brain which are particularly resistant to radiotherapy. This will be accomplished through analysing the comparative impact of particle radiotherapy delivered at both low and high (so called “FLASH”) dose rates on survival of normal versus the tumour cells, and how this this is mediated through specific effects on critical targets (DNA), under conditions of normal and reduced oxygen (hypoxia) which is important for solid tumours that are radiotherapy resistant. This will lead to development of optimal strategies using particle radiotherapy (protons) for the effective treatment of head and neck and brain tumours, minimising the commonly observed acute and long-term adverse side effects caused by the impact of the radiation on the associated normal tissues, and ultimately improve patient benefit and overall survival. 1